Reliability Modeling of Shoulder Fatigue and Recovery for Warehouse Operators Performing Dynamic Tasks

Project Summary The growing demand for e-commerce has resulted in an increase in warehouses and distribution centers, along with the needed workforce to run the operations. For improved efficiency, companies are shifting to parts-to- person systems for order fulfillment to reach productivity levels near 500 items/hour per worker. These systems create manual order picking jobs that are highly repetitive and primarily involve the arm and shoulder. Repetitive arm movements, performed for prolonged durations without adequate rest, can result in fatigue and discomfort for the shoulder, which can lead to musculoskeletal disorders (MSDs). Both stock movers and order fillers have above average incidence rates of injuries involving days away from work. Reducing the number of MSDs is an objective of the Transportation, Warehousing, and Utilities (TWU) Council and the Musculoskeletal Health (MSH) Cross-Sector NORA Agendas. Preventing MSDs depends on effective job design and work-rest schedules that minimize fatigue. However, current practice relies on fatigue models developed for static muscle loading, which fail to account for the dynamic demands experienced by order pickers. Thus, the primary objective of the proposed project is to enable prediction of fatigue and recovery resulting from manual order picking, focusing on parts-to-person systems with highly repetitious shoulder work. A secondary objective is to translate the research to practice (r2P) by providing practitioners with these predictive models to enable incorporation into their job evaluation and design practices. These objectives address the MSH cross-sector agenda call for research on the integration of real-time data with validated predictive models that address the variability in tasks and work- rest cycles. The models will be constructed from data collected during an in-lab study. Using a central composite design, fatigue development will be evaluated across a range of load levels and repetition rates, and recovery from fatigue will be measured across a range of rest durations. Subjects will complete four periods of order picking, separated by designated rest periods. Dependent measures will include subjective ratings of fatigue, kinematics data from wearable sensors, and task performance. These measures will be unified into a fatigue outcome metric using functional regression. Then, reliability theory will be applied to predict the unified outcome during repeated fatigue and recovery cycles as degradation and inverse degradation processes, respectively, accounting for task conditions, worker characteristics, and time. Field validation at a partner warehouse will be performed, where model predictions will be compared to worker subjective ratings for three order picking jobs. Once validated, the models will be packaged into a web-based application which will be disseminated to practitioners (output), enabling prediction of future worker fatigue levels, which is more informative than existing methods that provide a snapshot of the worker’s current condition or risk. Application of the revised models can facilitate improved workplace design and job scheduling to accommodate the capacities of order pickers, which supports the long-term goals of preventing musculoskeletal disorders and improving worker health (outcome).

Public health relevance
Project Narrative Order fulfillment in warehouses and distribution centers often requires highly repetitive exertions of the arm and shoulder, which can lead to muscle fatigue and ultimately musculoskeletal disorders. Current fatigue prediction methods are based on static tasks performed to exhaustion, and fail to capture the nature of warehouse work. The goals of the proposed project are to examine the fatigue development and recovery processes for repetitive order picking tasks and develop supporting models that can be used for predicting fatigue inclusive of task and worker characteristics.